Mast cell regulation of Th2 induction and tolerance breakdown in food allergy

While food allergy has emerged as a major health issue, treatment options are quite limited. There is an
urgent need to identify the specific environmental and endogenous factors that prime and then sustain allergic
responses to foods so that new mechanism-based therapies can be developed. We have found that, IgE-
activated mast cells, best known for causing immediate hypersensitivity reactions including food anaphylaxis,
actually play a separate but critical role as food allergen sensors and adjuvants for Type 2 immune responses
and that the activating effects of food-specific IgE on mast cells can be countered by IgG antibodies of
corresponding specificity. Important questions remain unanswered, however: 1) What specific aspects of
Type 2 immunity (Th2, ILC2, IgE+ B cells) are enhanced by IgE-activated mast cells?, 2) Are these effects
mediated by mast cell cytokines?, 3) Is the protective effect of IgG antibodies in vivo, suppressing Th2 and
enhancing Treg responses, mediated by their negative signals, delivered via FcgR2b, specifically in mast cells
and can responses to food allergens be attenuated by using specific monoclonal IgG antibodies to activate this
suppressive pathway? These questions will be answered in this project under the following aims:
AIM 1: Establish how IgE-activated mast cells promote food allergy:
1.1 Test the impact of IgE-activated mast cells in vivo on emergence of Th2, Tfh and IgE+ B cells and
evaluate the contributions of mast cell derived Th2 cytokines
1.2 Examine mast cell effects on emerging effector RORgt+ vs. pathogenic GATA-3+, IRF-4+, IL-4+ Treg
1.3 Evaluate reciprocal TGFb-mediated inhibitory effects of Treg on mast cell functions
1.4 Examine the influence of IgE-activated mast cells on ILC2 induction in vivo: Roles of mast cell- vs. gut
epithelial cell-derived cytokines
AIM 2: Determine how IgG:FcgR2b signals can reset the immune response in food allergy:
2.1 Evaluate the direct role of IgG inhibitory signals in mast cells in suppression of Type 2 and restoration
of functional Treg responses in food allergy
2.2 Evaluate the effects of high-affinity human monoclonal peanut specific IgG antibodies (and their IgG
subclass swap variants) cloned from single B cells transcriptomes on IgE-mediated basophil activation
2.3 Use our humanized mouse model of peanut allergy to test the effects of monoclonal peanut-specific
IgE on immediate hypersensitivity responses (systemic anaphylaxis).
2.4 Test IgG effects on Th, Tfh and Treg responses in the humanized mice

Public health relevance
Food allergy is a major health issue in developed countries with a prevalence of up to 6% in U.S. children. In this proposal the mechanisms whereby IgG antibodies to food promote food tolerance will be investigated. Their potential application to treat food allergy will be tested in a humanized mouse model of food allergy.